Project 2 - Becker

PROJECT SUMMARY
Osteoporosis, or low bone mineral density, is a common disease of aging resulting in 2.3 million fractures every year with
an annual societal cost of over $57 billion. First-line treatments for osteoporosis preserve bone mineral density by
inhibiting resorption in osteoclasts, resulting in an overall decrease in bone resorption and turnover. The side effects
associated with anti-resorptive therapies commonly decrease patient compliance with treatment recommendations. The
few anabolic therapeutics available facilitate bone formation in the osteoblast, but are reserved for high-risk patients due
to their cost, subcutaneous administration route, and lack of long-term safety data. The identification of new therapeutic
targets will help facilitate the development of well-tolerated alternative therapies that build high quality bone. There
remain significant gaps in our knowledge of proteins regulating bone mineral density, through both bone formation and
resorption in the osteoblast and osteoclast, respectively. With a critical need for accessible anabolic bone therapies, a
greater understanding of signaling pathways regulating osteoblast differentiation and mineralization will help in
identification of new therapeutic targets facilitating bone formation. DOCK7 is a guanine nucleotide exchange factor
known to regulate the Rho family of small GTPases. GTPases are molecular switches that activate cell signaling
pathways, controlling almost all cellular processes. This proposal presents exciting preliminary data demonstrating that
both global loss of DOCK7 and conditional deletion of DOCK7 in osteoblast progenitor cells leads to low bone mineral
density in vivo and decreases mineralization in vitro. These data suggest that DOCK7 is essential for the development of
normal bone mineral density and critical in regulating bone formation directly in the osteoblast. Furthermore, global loss
of DOCK7 results in a striking increase in osteoclast numbers, highlighting a role for DOCK7 in bone resorption. The
experiments proposed here will examine the mechanism by which DOCK7 controls bone metabolism in both the
osteoblast and osteoclast, exploring the novel molecular network of factors regulating bone remodeling using a
conditional deletion mouse model. Specific Aim 1 will examine the role of DOCK7 in mediating signals from
extracellular ligands critical to osteoblast function through small GTPases such as RAC1. We will also utilize an unbiased
approach designed to identify novel DOCK7 binding partners and regulatory networks associated with bone formation by
mass spectrometry and RNA sequencing. Specific Aim 2 will characterize the role of DOCK7 in bone resorption in vivo
and in vitro in osteoclast culture. This proposal will use innovative approaches to explore mechanisms by which DOCK7
influences bone metabolism in order to establish a set of novel factors regulating bone mineral density. These factors will
be the subject of future work exploring their therapeutic potential to prevent debilitating fracture events associated with
osteoporosis.